Development of Human-Selective Nerve Illumination Peptide for Surgery

Abstract A fundamental goal of surgery is function preservation and minimizing patient morbidity. Current nerve identification during surgery utilizes non-quantifiable criteria such as anatomy, texture, color, relationship to surrounding structures to distinguish nerves from non-nerve tissues. In instances of trauma, tumor invasion or infection, nerve identification using the above criteria may be challenging. Using white light reflectance, which is the standard mode of illumination in operating rooms, the visual difference between small nerves, such as cavernosal nerves important during radical prostatectomy or distal branches of the facial nerve important during surgery for salivary gland neoplasms, and adjacent tissue can be imperceptible. Our laboratory has extensive experience in developing molecularly targeted smart probes for surgical visualization of nerves. Recently, we have identified a novel peptide (HNP401) via phage display to have high level of human nerve binding. In this proposal, we aim to optimize HNP401 to enable its clinical translation for human surgery.

Public health relevance
Narrative There is an unmet need to improve the intraoperative visualization of nerves in order to preserve function and minimize morbidity following surgery. In this proposal, we aim to optimize HNP401, a peptide that we identified to have high human nerve labeling, for clinical translation. We aim to show that the use of HNP401-dye conjugate intraoperatively in patients undergoing resection of parotid neoplasm surgery is safe and has the potential to improve surgeon’s ability to visualize nerves prior to their exposure with the goal to minimize nerve injury.